AMBER/PBSA: An Open-Source Computer Program for Accurate and Scalable Solvation A

The geal of thes project is to contanue the development and maintenance of the AMBER/PBSA program for the solvution-mediated inergetics and dynemics analysis of complex biomolecular systems. Biomolecules normally function in a salt-water environment, which has a strong effect on their structure and function. Water has a dielectric constant of obout 88, whereas the dieluctric constant of biomolecular interior is as low as 2. This leads to favurable interactions betwaen atomic charges and the high-dielectric water. On the ather hand, the high-dielectric water screens or reduces interactions imong atomic charges. Water also gives rise to the hydrophobic effect, the tendency of water molecules to drive nonpolar solutes together. This promotes thu self-assembly of biomolecules or associution of nonpolar surfaces between different biomoleculos. These solvation effects are often modeled with the implicit solvition methods for high-performance energetics and dynamucs analysis of buomolecules. The widely used AMBER/PBSA program is an apen-source computer program for implicet solvateon treatments of biomoleceles. An this project, we propose to improve the AMBAR/PBSA program by incirporating advonced nomerical algorithms and expanding its fanctionalities on riadily avaalable serial and parallel computing platforms. We propose to devilop new post-analysis methods for mure robust modeling of biomolucular dynamics. Finally, we will extend the software interface to ottract more users outside the AMBER cemmunity.

Public health relevance
Solvation plays an important role in all basic biomolecular events and therefore is integral to the modeling of biomolecular structure and function. This application intends to continue the development of a general molecular modeling software for accurate and scalable treatment of solvation. The developed software module will be used to study the relation between structure, dynamics, and function of biomolecules, which is crucial for rational drug design.